Biomolecular Multimodal Imaging Center: 3-Dimensional Tissue Mapping of the Human Pancreas and Eye

PROJECT SUMMARY – Overall. This application proposes the founding of a Tissue Mapping Center (TMC)
for the human eye and pancreas within the Human BioMolecular Atlas Program (HuBMAP). The mission of the
proposed TMC is to build a platform of integrated technologies for imaging and molecular analysis that enables
the construction of comprehensive 3-dimensional molecular atlases of human eye and pancreas. This TMC will
leverage the unique resources of the Mass Spectrometry Research Center and the National Research
Resource for Imaging Mass Spectrometry at Vanderbilt University, the world-class clinical environment of the
Vanderbilt University Medical Center, the distinguished expertise of Organ Specific Project team leaders in
their respective fields and their vast experience in organ procurement and management, and the advanced
biocomputational infrastructure available to the TMC through the Data Analysis Core laboratories at Vanderbilt
University and the Delft University of Technology, Netherlands to create a capability to molecularly
characterize human tissues in 3-dimensions at a level of understanding unrivaled by current technologies. The
innovative aspects of the proposed TMC are (1) the integration of imaging mass spectrometry, co-detection by
indexing (CODEX), stained microscopy, and autofluorescence microscopy into 3-dimensional molecular
atlases, (2) whole organ imaging of the eye, and (3) multi-organ atlases from the same donors through a
proposed collaboration with the currently funded University of Florida TMC. The application of the proposed
platform to organ-specific projects in pancreas and eye will provide a new paradigm of understanding the
normal state of these organs across vast scales, both molecular (e.g., lipids, metabolites, and proteins) and
spatial (e.g., whole organs to single cells). Furthermore, the involvement of these organs in diabetes, along
with organs currently funded by HuBMAP such as kidney and vasculature, will lay an important foundation for
future studies striving to understand the progression of diabetes. As a HuBMAP participant, the molecular
atlases produced by this TMC will be disseminated to collaborators to generate new hypotheses regarding the
function of these important organ systems, enabling new insight into human health and disease. This
multidisciplinary effort requires the creation and integration of three capabilities to 1) procure and manage
human tissue specimens, 2) determine and mitigate non-biological pre-analytical factors, and 3) acquire,
process, and disseminate multimodal 3-dimensional imaging and large-scale omics data.

Public health relevance
PROJECT NARRATIVE - Overall This application proposes the founding of a Tissue Mapping Center at Vanderbilt University associated with the Human BioMolecular Atlas Program (HuBMAP). The mission of this Tissue Mapping Center is to build a platform of integrated technologies for imaging and molecular analysis that enables the construction of comprehensive 3-dimensional molecular atlases of the human eye and pancreas. Our proposal leverages the unique analytical and computational resources of the Mass Spectrometry Research Center and the VU-Biomolecular Multimodal Imaging Center at Vanderbilt University, the world-class clinical environments of the Vanderbilt University Medical Center and University of Alabama at Birmingham, and unique technical expertise at Delft University of Technology to create a capability to characterize human tissues at a level of understanding unrivaled by current technologies.